Define the oncogenic role of METTL3 in the pathogenesis of chronic lymphocytic leukemia

Project Summary
Aggressive chronic lymphocytic leukemia (CLL) remains incurable despite with improved chemotherapy
regimens and targeted therapies. Better understanding of the biology underlying aggressive CLL is expected to
design novel therapies.
We recently discovered that high spliceosome complex protein expression results in aberrant RNA splicing, is
associated with aggressive disease and serves as an independent predictive marker for poor prognosis in CLL,
highlighting RNA splicing dysregulation underlies aggressive CLL. Through an integrated transcriptome and
proteome analysis on normal and primary CLL B cells, we discovered that METTL3, an RNA methyltransferase
that deposits N6-methyladenosine (m6A) modification on mRNA, is strongly implicated as a key regulator for RNA
splicing in CLL. METTL3 is a highly expressed protein in CLL, associated with poor clinical outcome, and
significantly correlated with splicing factor protein expression. Moreover, efficacious small molecule inhibitors of
METTL3 have been developed and have shown promising results in hematological malignancy. Treatment with
METTL3 inhibitor results in growth defect in CLL cell lines and decreases RNA splicing factor protein expression.
Moreover, we have obtained evidence that METTL3 overexpression is oncogenic by rending IL-3 independency
in Ba/F3 cell line model. Based on these preliminary data, we hypothesize that METTL3 potentially acts as an
oncogene and drives the onset and progression of CLL through the regulation of RNA splicing network, making
it a potential target for treating aggressive CLL. To address this hypothesis, we propose to investigate METTL3
is required for both development and maintenance of CLL using murine models (Aim 1). We will dissect the
molecular mechanism underlying the targets of RNA splicing network in CLL and understand how they are
regulated by METTL3 (Aim 2). Moreover, we will determine whether METTL3 is a viable therapeutic target in
treating aggressive CLL and if targeting both METTL3 and RNA splicing regulatory network has a synergistic
effect in CLL (Aim 3).
Collectively, the results of the experiments proposed in this application will establish METTL3 as an CLL
oncogene, elucidate the m6A-modification on target transcripts that modulated by METTL3 to promote and
maintain CLL, and evaluate a new therapeutic approach for aggressive CLL.

Public health relevance
PROJECT NARRATIVE Aggressive chronic lymphocytic leukemia (CLL) remains incurable even though with improved chemo regimens and targeted therapies. We have discovered that METTL3 is one of the most upregulated proteins in CLL, associated with poor prognosis, and regulates RNA splicing by translational control of splicing factors. We thus propose to understand the role of METTL3 on the onset and progression of CLL and examine if co- targeting METTL3 and RNA splicing regulator can be an effective therapeutic option for aggressive CLL.